C. albicans interactions with S. mutans modulate cariogenic biofilm formation and virulence

Clinical microbiome studies show that C. albicans, along with elevated levels of S. mutans, in plaque (biofilm)
is strongly associated with severe early-childhood caries (S-ECC). Previously, we demonstrated that C.
albicans interacts with S. mutans and enhances the accumulation and virulence of plaque-biofilms, amplifying
the disease severity in vivo. We found that the presence of C. albicans activates S. mutans Gtf exoenzymes
production and promotes extracellular glucan synthesis, cross-feeding/co-metabolism, and acid production,
leading to rampant and extensive carious lesions (similar to those found in S-ECC) in a rodent caries model.
However, a key question remains unanswered. How C. albicans interacts with S. mutans to initiate the
pathogenic process? Recently, we discovered that C. albicans forms highly structured assemblages with S.
mutans that are uniquely found in the saliva of S-ECC patients. The C. albicans (Ca)-S. mutans (Sm)
assemblage binds avidly to apatite surface through hyphae acting as anchoring points. The attached
assemblage displays a new type of cell-group mobility that is mediated by the fungal hyphal formation and
elongation in saliva, which promotes rapid surface spreading with enhanced growth and acidogenesis causing
more extensive and severe enamel decay than either species alone. Conversely, inactivation of fungal growth
or filamentation prevents surface mobility/spreading and cariogenic activity.
In this proposal, we will investigate how C. albicans mediates this interkingdom assemblage formation and its
emergent properties to initiate pathogenic biofilms. Understanding the early events of Ca-Sm interactions that
coordinates effective colonization and rapid biofilm formation will provide new mechanistic insights about the
rampant nature and severity of S-ECC carious lesions, which remains poorly understood. Fungal transcription
factors (TF) and protein kinase (PK) networks play key roles in Ca filamentation but are highly influenced by
the niche environment. Preliminary data show that Ca hyphal morphogenesis in saliva is distinct from
previously studied conditions. Thus, we hypothesize that interkingdom assemblage and surface mobility in
the unique dental niche depend on novel C. albicans TF and PK networks that respond to saliva and
presence of S. mutans, enhancing surface colonization, biofilm spreading and virulence. In Aim 1, we
will identify C. albicans TFs and PKs and their target genes that regulate hyphal morphogenesis in saliva with
S. mutans mediating interkingdom assemblage formation, colonization, and mobility. In Aim 2, we will
investigate how TF and PK networks modulate biofilm initiation/spreading and enamel demineralization. Then,
in Aim 3, we will examine the role of TF and PK in biofilm virulence and their impact on oral microbiome and
caries severity in vivo. A comprehensive program from laboratory studies to in vivo investigations is offered to
understand the underlying mechanisms governing this highly virulent interkingdom interaction and its
implications in S-ECC, an unresolved public health problem.

Public health relevance
PROJECT NARRATIVE We found that a bacterial-fungal partnership mediated by Candida albicans is associated with severe early childhood caries (S-ECC). Understanding how fungi promote this interaction and biofilm virulence will advance the knowledge about S-ECC, which may help devise novel therapies to control this costly and intractable disease.